COMPARE LOW DOSE TO TRADITIONAL ACTH TESTS DURING GLUCOCORTICOID WITHDRAWAL

This protocol compares two tests of adrenal responsiveness (the traditional high dose ACTH test vs the new low dose ACTH test) in patients who have received exogenous glucocorticoids in the recent past. In these patients, the high dose test will be performed on a monthly basis, until it normalizes. After that, the low dose test will be performed until it normalizes. The time interval until this second event will be considered as the complete recovery of the hypothalamic - pituitary - adrenal axis, and should confirm the higher sensitivity of this new tool for assessing how long patents have to be careful about the possibility of adrenal insufficiency after steroid withdrawl.